MR-Guided Precision Tliermal Tfierapy of Retroperitoneal Tumors

We propose to design and test systems for the ablation of pancreatic cancer and other retroperitoneal malignancies using magnetic resonance thermal imaging (MRTI) within a 3 Tesla magnetic resonance. We will design and test ultrasonic delivery systems using ultrasonic applicators directly inserted into tumors (

Public health relevance
Pancreatic cancer is currently the fourth leading cause of cancer death in the United States, and treatment is generally of very limited effectiveness. We propose the development and extensive testing of systems for the thermal destruction of pancreatic and other retroperitoneal cancers using guidance available with MR imaging to visualize the heating process during treatment, and evaluate tissue damage following treatment. We will develop systems capable of effective minimally invasive treatment of such malignancies, while sparing normal tissues and improving patient outcomes.